Pleiotropy in LMNA-associated Arrhythmogenic Cardiomyopathy

Genetic testing for suspected familial cardiomyopathy and arrhythmogenic cardiomyopathy
(ACM) is becoming standard of care in the evaluation of affected individuals. The resulting
genetic information enables determination of etiology, provides insights on prognosis, and
identification of family members at-risk for inherited disease. This represents a first step
towards delivering Precision Medicine in cardio-genetics. Such advancements have exposed
unmet challenges for successful translation to precise therapies. One goal is genotype-specific
treatments for the affected individuals beyond standard cardiomyopathy therapy. Cascade
genetic screening of family members identifies a growing population of mutation carriers who
largely are in early- or even pre-clinical stages. Besides surveillance and treatment of early
symptoms, there is not much to offer them in terms of pre-emptive measures. This is an
opportunity intervene since mutant gene expression will begin at birth and exert incremental
effects that accumulate over may years prior to overt disease. To effectively address this cohort
we must better understand: 1) early biological perturbations that lead to disease, 2) whether
different types of mutations (even within the same gene) cause disease by variable
mechanisms, and 3) which cardiac cell-types are affected earliest. Pathogenic mutations in the
LMNA gene (encoding the lamin A/C protein) cause a progressive cardiomyopathy with
prominent arrythmias. There is considerable pleiotropy and phenotypic variability. LMNA is
widely expressed in differentiated tissues, including in all cardiac cell types (myocytes,
fibroblasts, macrophages, endothelial cells). Different mutations may affect different organs with
highly variable presentation. Within a given family however, the mutations appear to breed true
(age of onset, rate of progression, degree of arrhythmia, etc.). Through our Cardio-genetics
clinic we have recruited families with different LMNA mutations and have generated Induced
Pluripotent Stem Cells (IPSC) from peripheral blood monocytes to model LMNA cardiomyopathy
mechanisms. Our preliminary data indicate that different LMNA mutations associated with
variable phenotypes including, gene expression, nuclear morphology, electrophysiology, cell
migration, and cell death. Furthermore, these differences extend into non-myocyte cardiac cells
(cardiac fibroblasts). Our hypotheses are that: A) specific mutations in LMNA lead to ACM via
different molecular routes, B) different LMNA mutations impact different cardiac cell-types
leading to disease, and C) LMNA mutation-specific early molecular perturbations will affect
therapeutic responses aimed at disease pre-emption.

Public health relevance
Project Narrative: Genetic testing for familial heart disease identifies family members of affected patients who have a genetic disease trait and are not yet ill, but we have little to offer them to prevent the familial condition. We propose to use stem cells from families with lamin A/C -associated cardiomyopathy that leads to variably progressive heart disease to model how family-specific mutations affect the heart prior to development of symptoms. Successful completion of this project will lead to identification of new therapeutic methods to prevent disease development.